Cytometry and Imaging Microscopy

CYTOMETRY AND RESEARCH MICROSCOPY SHARED RESOURCE
PROJECT SUMMARY/ABSTRACT
The Case Comprehensive Cancer Center (Case CCC) Cytometry and Research Microscopy (CMSR) shared
resource has undergone a recent change in leadership that is designed to bolster the center's capabilities,
aligning with its mission to enhance its user experience. Under the shared leadership of Amar Desai and Judy
Drazba, this initiative is focused around three major goals during the upcoming funding cycle:
Aim 1 focuses on providing high-quality instrumentation and expert staff support. By ensuring equipment is
current and well-maintained, and offering tailored training and a repository of validated protocols, the CMSR will
improve research quality and efficiency.
Aim 2 is dedicated to facilitating interdisciplinary collaborations within the Case CCC. By fostering partnerships
and supporting the effective dissemination of research findings, the CMSR will play a pivotal role in enhancing
the center's collective research impact.
Aim 3 will expand service offerings in response to the evolving needs of the research community. This involves
securing funding for new technology and staying updated with the latest scientific advancements, thereby
ensuring the CMSR remains at the forefront of technological capabilities.
The CMSR has historically played an important role in facilitating projects across diverse research areas and
programs within the Case CCC, many of which have successfully secured external funding and resulted in
significant publications. In the current funding cycle, 535 investigators, 38% of whom were Case CCC members,
accounting for 52% of total usage, from all 6 of the Case CCC research programs used the SR. Looking forward,
the CMSR anticipates a future enriched with technological innovations and robust support for the Case CCC
community, emphasizing continuous improvement and a commitment to research excellence.